Investigating the role of TDP-43 mislocalization, structure, and post-translational modifications in the neuropathologically heterogeneous TDP-43 proteinopathies

PROJECT SUMMARY/ABSTRACT
The abnormal aggregation of transactive response DNA-binding protein of 43 kDa (TDP-43) in neuronal
inclusions is the defining pathologic hallmark of approximately half of frontotemporal lobar degeneration cases
(FTLD-TDP). Substantial heterogeneity exists in the clinical disorders associated with FTLD-TDP, which
reflects regional differences in neurodegeneration. Neuropathologic studies have suggested that the regional
cortical burden of aggregated TDP-43 may be responsible for neurodegeneration and ensuing clinical
heterogeneity. However, the molecular mechanisms underlying the region-specific accumulation of aggregated
TDP-43 are not understood. We hypothesize that: 1) in view of the subdivision of FTLD-TDP Types (A-D) and
variability in limbic-predominant age-related TDP-43 encephalopathy neuropathologic change (LATE-NC),
presence of atypical neuropathologic features may signal novel TDP-43 structures and post-translational
modifications (PTMs); 2) among TDP-43 proteinopathies, each neuropathologic phenotype is related to a
distinct structure of TDP-43 filaments, TDP-43 PTMs, and seeding properties. To investigate these
hypotheses, we propose to combine our collective expertise in neuropathology, molecular genetics, molecular
characterization of misfolded proteins, fluorescent multiplex immunohistochemistry, digital spatial profiling,
quantitative digital image analysis, and cryo-electron microscopy to study our study population, which includes
clinicopathologically well-characterized cases from the Dementia Laboratory’s Brain Library and cases from
other researchers. The project specific aims provide a foundation for in-depth analysis of TDP-43
proteinopathies. Aim 1 combines innovative neuropathologic methods for mapping TDP-43 inclusions,
misfolded TDP-43 in different neuronal and glial populations, glial response, and for determining how TDP-43
amyloid folds relate to the phenotype. Aim 2 leverages cutting-edge technology to identify novel PTMs that
coexist with the presence of misfolded TDP-43. RT-QuIC assay might reveal differences of TDP-43 seeding
properties. Aim 3 uses the most advanced cryo-EM technology to determine the structures of the TDP-43
amyloid filaments.

Public health relevance
PROJECT NARRATIVE The protein TAR DNA Binding protein – 43 kDa (TDP-43) has been shown to be involved in the pathology of diseases including Frontotemporal Degeneration (FTD), Amyotrophic Lateral Sclerosis (ALS), limbic predominant age-related TDP-43 encephalopathy (LATE), Alzheimer’s disease (AD) and aging related memory decline. Our proposal will use advanced techniques in digital neuropathology, molecular genetics, proteomics and molecular biology to carry out an in- depth analysis of TDP-43 and its involvement in these diseases. Results from this project may inform the design of diagnostic and therapeutic compounds that target pathological TDP-43, such as PET ligands and antibodies.